Evaluation of an implantable microdevice for rapid cancer drug screening directly in T cell lymphoma patients

Project Summary/Abstract:
Advanced cutaneous T cell lymphoma (CTCL) and peripheral T cell lymphoma (PTCL) have very poor
survival due to limited effective treatments. Three fundamental barriers have stalled drug development: 1) the
low incidence of each T--cell lymphoma (TCL) subtype, which limits sample availability and clinical trial
enrollment; 2) heterogeneity across subtypes, which further complicates biologic interrogation; and 3) a lack of
faithful model systems for in vitro and in vivo studies, which also cannot adequately assess immunotherapies.
Thus, there is a major scientific gap to direct rational clinical trial efforts for novel therapeutic regimens.
Here, we propose the use of an innovative implantable microdevice (MD) for in situ drug screening in patients
to identify the most effective cancer drugs and novel agents to direct future personalized treatment of TCL.
Our MD delivers up to 20 drugs of any class into spatially distinct regions of a tumor. It is delivered
percutaneously and retrieved 72 hours later by excising the device along with surrounding tissue with a
standard skin biopsy tool. This device allows testing of a range of relevant drugs directly inside the living
tumor, thereby preserving the native tumor physiology and, importantly, avoiding systemic toxicities. Drug
sensitivity is determined by histologic assessment of the tumor surrounding the drug chambers with
immunohistochemistry (IHC). The MD and the method for processing and analyzing tissue has been
validated across multiple cancer types in murine models and is being employed in an ongoing pilot study in
breast cancer. The specific aims of these studies will be to: i) determine the safety and feasibility implanting
and retrieving the MD in skin lesions of TCL; ii) assess local responsiveness of TCL to cancer treatments
delivered via the MD through IHC and use highly multiplexed cyclic immunofluorescence, a novel platform, to
characterize changes in the native immune microenvironment following drug treatment, and iii) correlate
genomic features of TCL with drug response to nominate potential therapeutic biomarkers and to correlate
these responses with a patient’s clinical and molecular response to systemically administered treatment. We
hypothesize that in situ pharmacological profiling of drugs in TCL has the ability to predict systemic
responses to standard of care therapies and therefore can serve as a rapid screen for multiple investigational
single or combination treatments. Additionally, genomic and immunophenotypic analysis of tumors may
assist in identification of predictive biomarkers of treatment. The results of our studies will direct clinical trial
efforts evaluating the most promising treatment strategies and usher in the era of precision medicine in TCL.

Public health relevance
Project Narrative: Advanced cutaneous T cell lymphoma (CTCL) and peripheral T cell lymphoma (PTCL) have very poor survival due to limited effective treatments and lack of predictive markers for selecting the optimal therapy for each patient. Here, we propose the use of an innovative “lab- in- a- patient” device, smaller than a grain of rice, that can be inserted directly into a patient’s tumor for rapid drug screening. Our study is the critical first step toward determining if the implantable microdevice may help select what experimental drugs should be tested in patients and ultimately help chose which approved cancer drug is most effective to treat a patient’s cancer.